Single Molecule Analysis of MAGUK Structure and Ligand Binding

This proposal focuses on post-synaptic glutamate signaling, which mediates excitatory
neurotransmission. Glutamate receptor signaling is organized by the membrane-associated
guanylate kinase (MAGuK) family of scaffold proteins. Scaffolds determine the outcome of
signal transduction by controlling the location of neurotransmitter receptors and connecting
them to downstream effectors. In particular, two homologous MAGuKs (PSD-95 and PSD-93)
play opposing roles in synaptic plasticity yet the basis for their differential activity remains a
mystery. A key factor in synaptic plasticity is post-translation modification (PTM) of the MAGuK
proteins, which have been missing in most studies that have been published to date.
This proposal investigates the posttranslational regulation of PSD-95 and PSD-93. Aim
1 will test the hypothesis that phosphorylation alters the structure and activity of MAGuKs. We
propose that a difference in the number and location of PTM sites elicits activity differences.
Aim 2 will test the hypothesis that palmitoylation, a lipid modification essential for synaptic
targeting, alters MAGuK activity and coverts them into the filament observed at synapses.
Studies to date focused on soluble proteins but palmitoylation is indispensable for activity. Aim
3 will test the hypothesis that phase transitions of MAGuKs regulate availability for receptor
binding. SynGAP, an essential synaptic protein, induces to liquid phase separation of PSD-95.
This can generate a dynamic “membrane-less organelle”. We will investigate the functional
effects of phase separation on receptor binding and structure.
We possess the only working reconstitution of scaffold interactions in the post-synapse
and provided the only kinetic description of MAGuK scaffolding activity. We will use our unique
expertise to address how PTM changes the activity of MAGuKs. We have pioneered novel
methods for structural refinement of proteins containing intrinsic disorder and generated the only
structural model of a full-length scaffold protein to date. We will use these approaches to
provide a mechanistic understanding of how MAGuK structure affects scaffolding. Our published
work suggests that proteins residing together on PSD-95 have “higher-order” interactions driven
by the enforced proximity. Describing the molecular events in excitatory signaling is a
fundamental challenge in neuroscience with direct relevance to brain development, memory and
learning, and many neurological and neuropsychiatric disorders.

Public health relevance
The MAGuK scaffold proteins organize glutamate neurotransmission through multiprotein interactions and have been implicated in diseases such as neurodegeneration following stroke, autism, epilepsy and schizophrenia. This proposal investigates the post- translational regulation of MAGuKs by phosphorylation, palmitoylation and phase separation using a novel reconstitution of the postsynapse along with state-of-the-art single molecule methods. Understanding the allosteric regulation of MAGuKs through physiologically-relevant reconstitution may provide a new avenue for the treatment of neurological and neuropsychiatric disorders.